Targeted degradation of RNAs by using small molecules

PROJECT SUMMARY
We propose a transformative approach, inspired by the mechanism of action of antisense oligonucleotides
(ASOs), to cleave RNAs with small molecules in cells and animals. As an alternative to ASOs, we will continue
to develop a class of small molecules that selectively cleave an RNA target, with supporting, validating data. Our
approach, dubbed ribonuclease targeting chimeras (RiboTACs), engineers small molecules to recruit
endogenous RNase L, expressed in a latent (hence RNase L) form. The chimeras, comprising an RNA-binding
module and an RNase L-recruiting small molecule, activate RNase L locally at the site of the desired target.
Indeed, the goals of our previously funded grant were successfully achieved, showing that the RiboTAC approach
cleaves oncogenic microRNA-21 sub-stoichiometrically and catalytically. Importantly, recent studies showed that
RiboTACs can induce cleavage of RNA targets even when the RNA binder is biologically inert.1 Further, we
designed two RiboTACs that degrade oncogenic mRNAs that encode difficult-to-target (generally considered
“undruggable”), intrinsically disordered proteins. One of these RiboTACs binds the internal ribosomal entry site
(IRES) in MYC mRNA, reducing MYC mRNA and protein levels in cellular models of triple-negative breast cancer
(TNBC), cervical cancer, Burkitt’s lymphoma, and multiple myeloma (MM).1 This c-Myc-RiboTAC will be fully
characterized in myeloma cell lines and patient tumor cells and then lead optimized. Collectively, we will establish
a method to program small molecules to cleave specific, oncogenic transcripts that encode “undruggable”
proteins in cells and in vivo.
In support of these goals, we propose in Aim 1 to comprehensively characterize c-Myc-RiboTAC against
MYC mRNA in vitro and in situ, a benchmark for lead optimization. Our preliminary studies show that c-Myc-
RiboTAC reduces MYC mRNA and protein levels in various MM cell lines, patient tumor cells, and in vivo.
Moreover, the extent of cleavage correlates with RNase L expression. In Aim 2, c-Myc-RiboTAC will be lead
optimized to deliver a proof-of-concept compound with properties amenable for in vivo testing. These drug
metabolism and pharmacokinetics (DMPK)-driven studies will optimize all three components of the RiboTAC, the
RNA-binding module, the linker, and the RNase L-recruiting module. We will rigorously assess top RiboTACs in
MM cell lines, including measuring selectivity transcriptome- and proteome-wide. Finally, in Aim 3 we will study
optimized RiboTACs for activity against a panel of MM patient tumor cells and in vivo. After confirming MYC
knockdown, we will assess their effects on: (i) cell proliferation; (ii) cell survival; and (iii) expression of epithelial-
mesenchymal transition (EMT) and MM cancer stem cell markers. The RiboTAC with the broadest activity
against MM cells will be evaluated in vivo.

Public health relevance
PROJECT NARRATIVE Herein, we propose to further develop the small molecule equivalent of antisense oligonucleotides, where we have engineered small molecules that selectively bind to a given RNA target to recruit an endogenous RNase, a strategy that provides a powerful and facile platform for selective destruction of any RNA. We will apply these methods to disable oncogenic MYC mRNA, which encodes an undruggable, intrinsically disordered protein (IDP), and seek to improve small molecule selectivity, potency, and efficacy in myeloma cancer cells isolated from patients and in vivo. Importantly, our method will be developed into a general platform to drug IDPs encoded by mRNAs that harbor regions of structure.